ROLE OF ENDOGENOUS OPIATES IN SECONDARY HYPOGONADISM

This project will investigate the role of endogenous opioids in the pathophysiology of idiopathic, adult male secondary hypogonadism. After first characterizing this population with provocative testing of the hypothalamic-pituitary-gonadal axis, we will evaluate gonadotropin and testosterone response to opiate inhibition with naloxone; an opiate antagonist, in a single blind fashion with age-matched controls.